Genetic Vulnerability for Sustained Multi-Substance Use in MVP

Harmful substance use (alcohol, tobacco, and/or prescription opioids) is common and twin studies suggest a
substantial genetic role. Further, combined use of alcohol with tobacco and tobacco with opioids, commonly
occurs suggesting that environmental and genetic risks for these behaviors overlap. However, identified
genetic variation explains only a small proportion of the phenotypic variation for individual or combined
substance use. Studies aiming to identify shared genetic pathways across substances (pleiotropy) have
yielded inconsistent results. Among the major challenges to gene finding for these traits are phenotypic
ambiguity, measurement bias, and inadequate statistical power to detect the small genetic effects associated
with complex disorders. Individual clinical assessments often do not capture all substances of interest or
relevant clinical factors (e.g., chronic pain) and are subject to substantial variation and bias depending upon
the patient's health state, the clinical setting in which the assessment occurs, and the clinician making the
assessment. Administrative International Classification of Diseases (ICD) codes derived from these
assessments are frequently used because they are readily available for large numbers of subjects, but they
can add another layer of inaccuracy and bias. The unique, rich, longitudinal clinical data available within the
Veterans Healthcare Administration (VA) combined with data available from the Million Veteran Program
(MVP) is enabling us to overcome these limitations. We began with widely available and repeated electronic
health record (EHR)-based metrics: AUDIT-C for hazardous alcohol; current/past/never smoking status for
tobacco; and morphine equivalent daily dose (MEDD) from pharmacy fill/refill records for prescription opioids.
Longitudinal summary metrics derived from these measures were initially validated in the Veterans Aging
Cohort Study (VACS) and then extended to MVP, validating them against additional criterion standards and in
a much larger, more generalizable, sample. Importantly, MVP also allowed us to validate against genetic
criterion standards, previously identified single nucleotide polymorphisms (SNPs). This yielded Electronic
Health Record (EHR)-based, CritErion-validated Longitudinal (ExCEL) phenotypes that were substantially
more strongly associated with criterion and content standards for alcohol (1, 2), tobacco (3), and prescription
opioids [Becker, in preparation] than alternative phenotypes. Genome-wide association studies (GWASs) of
alcohol, tobacco, and opioids using ExCEL phenotypes are underway and have both reproduced prior findings
and yielded many novel associations of SNPs and genes with these conditions. We have shared ExCEL
phenotypes with Alpha and Beta project groups via the MVP wiki and the MVP Phenotype Workgroup. We are
currently conducting joint GWASs of ExCEL phenotypes for tobacco and alcohol (Zhao and Dao) and will soon
initiate joint GWASs of ExCEL phenotypes for tobacco and opioids. Because chronic pain is strongly
associated with substance use, we propose to develop, validate, and apply an ExCEL phenotype of chronic
pain using repeated measures of the Numeric Pain Rating Scale (NRS) and validating it against functional
impairment due to pain from the MVP survey and a genetic risk score based on previously identified SNPs. In
the next four years, we will use ExCEL phenotypes to conduct GWASs of substance use (alcohol, tobacco,
and prescription opioids) and chronic pain, treating chronic pain as a confounder, as a necessary exposure,
and as a unifying genetic link. We expect that our analyses will reveal the extent to which genetic factors are
shared between chronic pain and substance use and shed light on how pain may influence the expression of
genetic risk factors for substance-related traits.

Public health relevance
Substance use (SU) disorders collectively represent the single most preventable cause of disease, disability, and death in the United States. Veterans are at higher risk than the general population for complications related to SU. Chronic pain is a risk factor for opioid drug use and is compounded by the other SU. Although SU and chronic pain both have a heritable component, isolating specific genes that affect risk across substances and that may also affect risk for chronic pain has been hampered by small sample sizes and ambiguous phenotypes. We will use the Million Veteran Program sample with SU phenotypes based on longitudinal quantity-frequency data from the VA electronic health record, and novel techniques in genome- wide association computational analysis to overcome the limitations of previous work and advance the field by enhancing the screening, diagnosis and treatment of multi-SU and SU disorders. Finally, incorporating pain phenotypes will help to elucidate the genetic variation that contributes to their frequent co-occurrence with SU.